Otolaryngology R25 Mentored Research Pathway at Washington University

PROJECT SUMMARY/ABSTRACT
The Department of Otolaryngology-Head & Neck Surgery at Washington University has had continuous
T32 funding for research training during the otolaryngology residency program since 1985. This application
seeks to transition funding for research training during otolaryngology from the T32 to R25 program in
response to RFA-DC-20-002.
The Overall Goal of the Otolaryngology R25 Mentored Research Pathway Training Program is to
provide outstanding research and educational opportunities to medical students and resident-investigators
in otolaryngology to stimulate an interest in research as part of their future career goals.
The Specific Aims of the R25 Training Program are to:
1) Provide mentored research experience with research preceptors conducting basic, clinical,
translational, or behavioral research in diseases and conditions related to deafness and other
communication disorders.
2) Provide core courses related to the fundamentals of clinical and translational research created by Ors.
Piccirillo and Kallogjeri and delivered as short courses, tutorials, video modules and elective courses to
ensure trainees acquire in-depth knowledge of relevant basic, clinical, translational, and behavioral
research techniques directly related to their research experience and/or research project.
3) Provide access to curricula, seminars, workshops, and tutorials that focus on topics related to
professional career development skills.
4) Evaluate all research education program components and track trainees' career development over time.
5) Actively disseminate the digital core courses to encourage adoption by other otolaryngology residency
training programs.
The foundation of the R25 Program is the mentored research experience with one or more of the
program faculty and research preceptors. The diverse program faculty and research preceptors have a
proven record of providing outstanding mentored research opportunities.
Each year, two predoctoral medical students and two post-doctoral otolaryngology residents will enter the
research education pathway. The medical students will spend 9 months in the mentored research activity
laboratory and the resident-investigators will spend two years at 80% effort after the PGY-2 year of clinical
residency training. The R25 will support two medical students and four resident-investigators per year.
Robust tracking and evaluation of the TL 1 program, trainees, and alumni will be used to determine the
effectiveness of the training methods and identify opportunities to improve the Program.

Public health relevance
PROJECT NARRATIVE The goals of this new research education program are to introduce outstanding predoctoral medical students to the excitement and challenges of research to stimulate an interest in research as part of their future career goals and to train postdoctoral otolaryngology resident-investigators in the tools and techniques of research so that they may compete successfully for individual NIH-sponsored research awards and eventually assume leadership roles in academic medicine. The successful completion of these goals will result in increased numbers of diverse, well- trained physician-scientists who will lead multidisciplinary research teams addressing complex health problems in the mission areas of NIDCD.